Administrative Core

ABSTRACT The overall goal of the Administrative Core is to ensure timely and effective execution of proposed work through management, coordination and supervision of the Project and Core Leaders and research personnel and resolution of any conflicts that may arise. The Administrative Core will ensure that the interaction of the Projects and Core B are optimized so as to succeed in the following goals: identification of new gene functions, drug targets and metabolic responses in Mtb, correlation of these with the transmission phenotype of clinical isolates, development of new tests for a TB treatment's transmission-blocking potential, new animal models for aerogenic transmission of TB that allow experimental modification of the genetics of Mtb and the characteristics of aerosolized droplets, and consideration of new approaches to reduce R0.